Frontal and Temporal Lobe Interactions in Rat Models of Normative Aging and Alzheimer's Disease

ABSTRACT
Dramatic advances have been made in recent years in the theory of how information is represented, stored
and retrieved in neural networks and in the methodology for studying interactions among groups of neurons.
Animal models of aging in rodents suggest that altered connectivity and plasticity mechanisms within the
hippocampus contribute to altered network function associated with changes in spatial cognition. In addition to
changes in temporal lobe-dependent episodic memory, some of the earliest alterations detected in memory
across the lifespan occur in frontal lobe-dependent tasks, including working memory and attention. Each of
these cognitive functions, of course, is essential for effective interaction with our environment. In humans, the
proportion of people across the USA over 71 who are demented, from all causes, is 14%. This suggests that it
is critical to understand normal cognitive aging processes in their own right, as this reflects 86% of aged
individuals over 71. It is also critical to understand the mechanisms that underly devastating
neurodegenerative disorders such as Alzheimer's disease. The two Aims of this proposal use two different
animal models – one that represents a model of normative human aging and another that models many of the
pathological characteristics of Alzheimer's disease. The goal is to understand how brain circuit interactions
critical for memory are altered in both normal aging and in neurodegenerative disease. This proposal focuses
on the interactions between the hippocampus and the medial prefrontal cortex (mPFC). Both structures are
known to be critical for cognition and are vulnerable in aging and in neurodegenerative disease.
Aim 1 examines spatial working memory and the effect of age on the dynamics of network interactions
between the hippocampus and prefrontal cortex in young and aged rats while performing a continuous
alternation task on a W-track apparatus. The questions addressed in this Aim include how the normative aging
brain adapts to changes in intrinsic network dynamics within each structure, between the direct projection from
ventral hippocampus to mPFC, and how these structures interact or compete during aging to find solutions to
this spatial working memory problem. Aim 2 uses a relatively newly established rat genetic model of AD, the
TgF344-AD rat, that carries the mutant human APP and PS1 genes, but spontaneously manifests tau
pathology, hippocampus cell loss and cognitive dysfunction by 15 mo of age. We have developed a more
constrained spatial sequence memory task, modeled after the W-track, that we call the Fan Maze. The smaller
apparatus allows us to adapt a massively high-density recording technology (the Neuropixels probe) to
chronically implanted freely behaving rats. The ability to record from ensembles of cells across the
hippocampus and mPFC while rats perform tasks dependent on the interactions between these brain
structures, will allow us to bridge the gap between principles learned from studying animal models of normative
aging and Alzheimer's disease, to those that underlie the neural basis of human cognitive aging and disease.

Public health relevance
Project Narrative This proposal is to understand how brain circuits critical for cognition are impacted by aging and Alzheimer's disease. It uses two rodent models – one a rat model of normative aging and the other a rat model of Alzheimer's disease. We examine two brain two brain structures that are essential for memory, known to be impacted by age and by neurodegenerative disease, and apply behavioral and electrophysiological methods to better understand the neural basis of human cognitive aging and neurodegenerative diseases.